CPCCRN PRECISE Supplement

Project Summary/Abstract
The Personalized Immunomodulation in Pediatric Sepsis-induced MODS (PRECISE) study that is currently
being conducted by the NICHD’s Collaborative Pediatric Critical Care Research Network (CPCCRN) uses real-
time immune phenotyping to assign subjects to treatment or observational cohorts based on their immune
status. The 24-site, 1000-subject PRECISE study currently uses the whole blood ex vivo LPS-induced TNFα
production capacity (TNFα response) assay to diagnose severe innate immune suppression, termed
“immunoparalysis”. An alternative approach to diagnosing immunoparalysis is the measurement of the
expression of the antigen-presenting molecule HLA-DR on the surface of circulating monocytes (mHLA-DR)
using flow cytometry. The current application proposes the addition of mHLA-DR expression measurement,
which is now much more feasible for multi-center use than at the time of the original study design, to the
PRECISE immunophenotyping panel. Though mHLA-DR expression will not be used to drive cohort
assignment, its addition will allow for the evaluation of mHLA-DR expression as a potential diagnostic tool that
could drive treatment in the future. This is important because there are currently no FDA-approved laboratory
tests for the diagnosis of immunoparalysis, and if the PRECISE study is positive, there is currently no way to
rapidly generalize its results. The addition of mHLA-DR expression to the dataset provides a unique and time-
limited opportunity to understand if thresholds of mHLA-DR expression exist that equate to the TNFα response
cutoff used in the PRECISE study; and to understand if mHLA-DR expression can serve as a predictor of a
favorable response to GM-CSF. If positive, this could greatly accelerate the movement of immunoparalysis
diagnostics to the clinical laboratory, to the benefit of critically ill children.

Public health relevance
Project Narrative Relevance Severe immune failure, termed immunoparalysis, is a common feature of sepsis-induced multiple organ dysfunction syndrome (MODS) in children, yet there are no FDA-approved assays to diagnose immunoparalysis. The Personalized Immunomodulation in Pediatric Sepsis-induced MODS (PRECISE) study uses real-time immune phenotyping to assign subjects to treatment arms based on their immune status, using the TNFα response to diagnose immune paralysis. We propose to add the measurement of monocyte HLA- DR expression to the PRECISE immune phenotyping panel in hopes of provide an alternate route by which immunoparalysis testing can move more quickly to the clinical laboratory.